Transformative microscopes to image across spatiotemporal scales

Project abstract
How molecular organization and activity leads to tissue level outcomes is, arguably, one
of the big remaining open questions in biology. Bridging these two areas is key to
biomedical advances, yet is technically challenging because we cannot observe with
molecular precision at the tissue scale. While optical microscopy is the method of choice
to observe architecture and dynamics within living cells and organisms, it has
fundamental limitations in spatiotemporal resolution and optical penetration depth. Thus
our most detailed observations of cellular dynamics and ultrastructure have been limited
to single cells that were far removed from their physiological context.
Here I propose to significantly expand the reach of super-resolution microscopy to
encompass tissues and whole model organisms. This lies far outside of the capabilities
of the current state of the art and requires significant progress in volumetric acquisition
speed, sensitivity and optical penetration depth. I propose to advance the field by
combining three different fields of microscopy. Some of these combinations are non-trivial
and thus have not been experimentally tractable so far. I propose novel concepts that can
bridge these different fields and overcome technical and fundamental limitations.
Furthermore, a novel adaptive sampling approach that only images the most informative
voxels at the highest resolution will overcome fundamental barriers to high-resolution
imaging over large volumes. I hypothesize that my new instrumentation combined with
an intelligent sampling strategt can improve acquisition speed up to 100 fold while
reducing phototoxicity and data storage needs. The resulting new microscope technology
will dramatically speed up high-resolution imaging over large volumes and hence will
enable large volume imaging experiments that have been prohibited by either lack of
spatial resolution, optical penetration depth or acquisition speed.

Public health relevance
Project Narrative Throughout my career, I have worked on improving optical microscopy in terms of spatial and temporal resolution and optical penetration depth through various technological innovations. I hypothesize that by synergistically combining these different fields of optics in novel ways and by leveraging advanced computational post- processing, optical microscopy across disparate spatial and temporal scales will become possible. My research program will provide the technology to link subcellular events to tissue level outcomes, a capability that will advance biomedical research.